Enrichment Program

PROJECT SUMMARY/ABSTRACT ENRICHMENT PROGRAM
The WU NORC Enrichment Program will be directed by Dr. Brian DeBosch. The purpose of the
Enrichment Program is to promote education, collaboration, growth and success within the NORC
membership and attract qualified faculty to become NORC members. The Enrichment Program provides
research seminars at WUSM, specifically a weekly NORC Metabolism, Obesity, Nutrition and Diabetes
Seminar, a weekly NORC Work-in-Progress Research Seminar that allows critical peer feedback among
NORC investigators, a monthly Nonalcoholic Fatty Liver Disease Interest Group that includes
investigators from St. Louis University, an annual didactic course provided by the Clinical Science
, and (in conjunction with the Dissemination
and Implementation Science Core) an annual graduate-level course in Dissemination and
Implementation Science that is available free-of-charge (without credit) to NORC members. The NORC
Administrative Core supports the Enrichment Program by organizing and scheduling the speakers for the
weekly NORC Research Seminar and the weekly Work-in-Progress Research Seminar, responding to
requests for lectures on nutrition and obesity topics throughout the medical center and arranging for an
appropriate speaker, disseminating announcements, and arranging logistics for NORC visiting
professors.